Deciphering the amine/acetylation code of PNAG through comprehensive libraries of synthetic oligosaccharides for effective anti-microbial vaccines

Project summary
With the prevalence and challenges of antimicrobial resistant microbes, there is an urgent
need to develop novel vaccines to prevent these infections. Poly-β-(1−6)-N-acetylglucosamine
(PNAG) is an attractive target for vaccine development as it is a key virulence factor present on
the surface of many species of non-viral pathogens. Since naturally existing PNAG can bear a
varying number of free amines rather than N-acetamides on its glucosamine units, it is not known
how the numbers and the positions of amines vs N-acetamides of PNAG (amine/acetylation code)
can impact the antigenicity and protective efficacy generated by PNAG-targeting vaccines. Fur-
thermore, PNAG antigens require a carrier system to elicit an anti-PNAG antibody response for
protective immunity. To thoroughly probe the key structural features of PNAG for effective vac-
cines, an interdisciplinary team has been formed to integrate expertise in carbohydrate chemistry,
microbiology and vaccinology. In aim 1, new methodologies will be established to expedite the
synthesis of a comprehensive library of PNAG pentasaccharides with systematically varied
amine/acetylation patterns, as well as longer PNAG glycans with well-defined sequences. The
library of PNAG glycans will be covalently linked with a powerful immunogenic carrier, i.e., mutant
bacteriophage Qβ, in aim 2. The immunogenicity of the conjugates in both mice and rabbits will
be investigated with the optimal linker, antigen density and adjuvant established to elicit high-
titered, and long-lasting protective antibodies to PNAG. Subsequently, the effectiveness of the
optimal vaccine candidates and adjuvant will be evaluated against Staphylococcus aureus includ-
ing methicillin resistant Staphylococcus aureus (MRSA) strains. In aim 3, as currently there are
no approved vaccines available to protect against Neisseria gonorrhoeae, to fill this critical clinical
need, mQβ-PNAG based vaccine will be tested against Neisseria gonorrhoeae experimental in-
fections. The efficacy of the vaccine will be established in multiple challenge models to lay the
groundwork for future translation. This project highlights the exciting potential of synthetic PNAG
glycan aided epitope discovery for next generation vaccine design.

Public health relevance
Project narrative An opportunity to produce a vaccine that can be used against many different microbial pathogens has arisen from the research conducted over the past 35 years investigating the properties of a conserved surface polysaccharide molecule known as PNAG for poly-N-acetyl glucosamine. But to make an effective vaccine to PNAG, investigations into the variable structural features of PNAG are needed to determine which ones are the best for use as the vaccine immunogen. This project will test an extensive library of synthetic PNAG oligosaccharides to decode the specific PNAG structure as the most suitable for a vaccine to prevent infections including those caused by multiply-antibiotic resistant microbes from Staphylococcus aureus and Neisseria gonorrhoeae.